SPHINCTER OF ODDI DYSFUNCTION--ENDOSCOPIC STENTING AS THERAPY

The purpose of this study is to determine whether endoscopic stenting is effective therapy in and, when successful, predictive of the presence of sphincter of Oddi dysfunction.